ANALYSIS OF PROPAGATION OF LIGHT IN TURBID BIOLOGICAL TISSUES

Many of the clinical research projects of the laser biophysics group involve the interaction of light with tissue (e.g., laser microsurgery, Laser Doppler blood flow measurements, photo dynamic therapy of cancer, noninvasive platelet assessment). In order to more fully quantitate these techniques, we have undertaken theoretical modeling of light propagation in biological tissues and turbid media. Analytical equations have been devised characterizing various parameters of photons illuminating a tissue surface (probability of surface re-emission at a given distance, mean path before re- emission, mean depth of penetration, probability of absorption with depth). These expressions have been used to interpret empirical measurements on living tissues and to quantify better a variety of clinical measurements (e.g. Laser Doppler blood flow and volume measurements, dosimetry in PDT of cancer, and remote sensing of atherosclerotic plaque).